Development of an Effective Strategy to Block Nab Activity for AAV Brain Transduction

Adeno-associated virus (AAV) vectors have been successfully employed in patients with rare neurological
diseases. Recently, two AAV based gene therapy drugs have been approved by the FDA, Luxturna been
valued at $850,000 with a one-time application for blindness and Zolgensma at $2,100,000 for spinal muscle
atrophy. AAV vector mediated gene therapy has shown to be a potentially huge market. Although successful in
clinical studies for neurological disorders, one of the major concerns for effective AAV brain application is high
prevalence of neutralizing antibody (Nab) in humans. In the general human population, over 95 % of
individuals are infected by AAV and, on average, 50 % of them develop Nabs. The inhibition effect of Nabs on
AAV brain transduction has been well documented regardless of delivery routes (direct intra-brain injection or
systemic administration). Several approaches have been exploited to escape AAV Nabs, including chemical
modification, use of different AAV vector serotypes, AAV capsid engineering, and biological depletion of Nab
titer (empty capsid utilization, B cell depletion, plasma-apheresis, and Ig proteases). Generally, these
approaches have low efficiency, unwanted side effects, or AAV tropism change. Recently, Nabgen has
developed a vector independent protein-based strategy to universally block Nabs using a unique mycoplasma
derived protein, termed Protein-M. Protein-M is able to interact with immunoglobulin from any species without
antigen dependence by binding to variable regions on the antibody light and heavy chains. Using human IVIG
and serum from AAV immunized mice, we have found that Protein-M reduced AAV vector neutralization over
100 fold when compared to control group without Protein-M in vitro. Most importantly, we have observed that
Protein-M was able to retain AAV transduction over 1000 fold in mice with adoptive transfer of Nab positive
serum. So far, this is the most effective strategy to evade AAV Nabs. To explore the application of Protein-M in
patients with AAV brain targeted therapy, it is imperative to address the efficacy of Protein-M to protect AAV
from Nabs for brain transduction in subjects with Nabs. In this proposal, we will first study the effect of Protein-
M co-administered with AAV vectors on AAV Nab blockage via direct injection into the brain in mice with pre-
immunization of AAV (Aim 1). Next, we will study the effect of Protein-M via systemic injection on brain
transduction after direct delivery of AAV vectors (Aim 2). If successful, this novel and effective technology will
extend the benefits of AAV targeted gene therapy to every patient with brain disorders and AAV Nabs.

Public health relevance
Gene Therapy with adeno-associated virus (AAV) vector has shown promise in patients with central nervous system (CNS) disorders in recent clinical trials, however, these trials are exclusively applied to the patients without AAV neutralizing antibodies. We have demonstrated that protein M derived from mycoplasma was able to potentially block AAV neutralizing antibody activity in vitro and in mice with adoptive transfer of AAV immunized serum. This proposal will further study the effect of protein M on protection of AAV brain transduction in pre-immunized mice.